Retrotransposon derived promoters drive alternative host gene isoforms with important developmental functions

Project Summary
Most mammalian retrotransposons are strictly silenced in development and physiology, yet induction of
some retrotransposons can be observed during specific developmental processes. Interestingly, a portion
of the reactivated retrotransposons, particularly LTR retrotransposons, confer a gene regulatory role, at
least in part, by acting as alternative promoters to drive chimeric transcripts with proximal protein-coding
genes. Such retrotransposon promoters frequently alter gene structure and/or gene expression, yet their
functional importance remains largely unclear.
Mammalian preimplantation embryos are an excellent experimental system to probe the functional
importance of retrotransposons. Dynamic induction of retrotransposons in preimplantation embryos have
been observed in all 8 mammalian species examined, and the global retrotransposon expression profiles
across mammalian species are similar. Using published single-cell RNA-seq data from mouse, human,
primate and livestock preimplantation embryos, we discovered hundreds of retrotransposon promoters,
which drive preimplantation-specific, proximal gene isoforms. Interestingly, most retrotransposon
sequences and integrations are species specific, yet many retrotransposon promoters yield gene
isoforms that encode evolutionarily conserved proteins. Hence, these data suggest that retrotransposon
promoters can regulate conserved protein sequences and bestow them with species-specific gene
regulation. One of such evolutionarily conserved retrotransposon driven gene isoform, Cdk2ap1N(MT2B2),
encodes an N-terminally truncated isoform for Cdk2ap1, a negative regulator for cell proliferation by
repressing Cdk2. Cdk2ap1N(MT2B2) is generated by an MT2B2 promoter, whose deletion in mice yield
reduced cell proliferation, impaired implantation and embryonic lethality. This is among the first study
demonstrating an essential function of a retrotransposon element in development. Here, we hypothesize
that retrotransposon-mediate gene regulation play an essential role in mammalian preimplantation
development. Using bioinformatics prediction combined with experimental validation, we propose to
comprehensively and accurately categorize retrotransposon-promoters in mouse, primate and livestock
preimplantation embryos, and elucidate the diverse molecular mechanisms for retrotransposon-mediated
gene regulation. Additionally, we will employ a highly efficient CRISPR technology, CRISPR-EZ, to
generate mouse deletion mutants for selected retrotransposon promoters or for the corresponding
canonical gene isoforms. We will compare the roles of retrotransposon-dependent gene isoform and the
canonical gene isoform, elucidate the molecular mechanisms of their action and explore the evolutionary
significance of such regulation. Taken together, these proposed studies will generate a comprehensive
atlas of retrotransposon-dependent gene regulation during preimplantation development, and provide a
new paradigm to investigate retrotransposon functions both computationally and experimentally.

Public health relevance
Project narrative Induction of specific retrotransposon families have been observed during preimplantation development of multiple mammalian species, generating numerous retrotransposon derived promoters that drive alternative, preimplantation specific gene isoforms. Using mouse genetics, next generation sequencing, cell and molecular biology, our proposed studies will comprehensively categorize retrotransposon-dependent gene regulation, functionally characterize specific retrotransposon in essential developmental processes, and elucidate the importance of retrotransposon in gene regulatory diversity among different mammals.